Mechanisms of immune control of intratumor heterogeneity and clonal competition

PROJECT SUMMARY/ABSTRACT
Intratumor heterogeneity (ITH) and clonal evolution pose tremendous challenges in designing effective
and durable cancer therapies. This is highly relevant for PCa, a prime example of a highly heterogenous disease
where fluctuating cellular subpopulations (“clones”) with distinct mutational and phenotypic profiles can coexist
and evolve independently, diversify and compete during the course of the disease. The majority of ITH studies
centers on genetic determinants, while non-genetic variability such as due to spatial clonal distributions and
interactions of tumor subpopulations with each other and with the immune TME remain poorly understood. These
mechanisms are multifaceted, context-dependent and difficult to investigate experimentally in vivo. However,
these complex interactions might hold powerful anti-tumor interventions. For instance, mechanisms of elimination
of “loser” cells/clones could be exploited to lower overall tumor fitness and new targeted therapies could be
developed to counteract the factors that enable clonal dominance. We recently generated new reductionist
models of ITH that reflect, at least in part, the clonal fitness diversity of human PCa. By incorporating multicolor
lineage tracing in mouse models, longitudinal organoid studies and single cell transcriptomics, we showed that
less severe models accommodate the coexistence of multiple growing tumor subpopulations. In contrast,
aggressive tumors exhibit a drastic and rapid clonal reduction, emergence of larger dominant populations as
slower-growing populations are out-competed by fast-growing ones in vivo and in vitro, and massive TME
remodeling. In the same time, some minor populations persist and might serve as a reservoir for drug-resistant
clones. Moreover, the minor populations have distinct immunoediting molecular signatures marked by increased
expression of Cxcl9/Cxcl11 and MHC class II members. We hypothesize that direct competition mechanisms
between dominant and minor clones within specialized TME niches coupled with fitness effects of the immune
system on clonal expansions determine the ITH in PCa. The goal of this proposal is to identify molecular
mechanisms and cellular contexts underlying clonal interactions with each other and with TME by pursuing 1)
Functional mapping of tumor competitive landscapes in mouse models of PCa by spatial transcriptomic
analyses and 2) Elucidate the role of Cxcl9/11 in reducing the fitness potential of minor clones by novel
competition-chemotaxis and T-cell infiltration organoid assays and in vivo immunomodulatory interventions.
Results from these studies will not only greatly expand our understanding of population-level interactions
in tumors, but also uncover new targetable immunoediting mechanisms that operate at clonal level in driving
clonal diversification and selection with impact on preventing progression to advanced disease and drug
resistance.

Public health relevance
PROJECT NARRATIVE Intratumor heterogeneity (ITH) and continuous genomic and phenotypic diversification of tumor subpopulations remain major sources of treatment failure in cancer. While the accumulation of mutations has been extensively studied, tumor landscapes remain an unknown geography leaving important non-genetic determinants of ITH unidentified. To uncover the spatial organizational principles of tumor landscapes and cellular networks we propose a “zooming-out” approach through spatial transcriptomics and single cell multiomics followed by “zoom- in” on key regulators of clonal-immune interactions through organoid cultures and in vivo immunomodulatory interventions to steer the tumor landscape towards clonal equilibrium and clonal eradication.